Medical University of South Carolina NCORP Community Site

PROJECT SUMMARY
The Medical University of South Carolina/Hollings Cancer Center (MUSC/HCC) aims to expand and
enhance the NCORP trial portfolio by accruing from other medically overlooked groups into NCORP
studies, share expertise and experience on broadening recruitment and retention and leveraging local
knowledge within the NCORP community, and contribute to the development and implementation of
cancer care and cancer delivery research. During the current project period, the MUSC NCORP-MU,
which is comprised of three MUSC/HCC sub-affiliates and community oncology primary affiliates, has
made significant contributions to the NCORP program through the effective and efficient accrual of
historically overlooked patient populations and leadership that has shaped the scientific agenda for
clinical trials, disproportional cancer health outcomes, and cancer care delivery research. These
accomplishments were made possible through a highly invested and transdisciplinary investigative team
consisting of David T. Marshall, MD (Radiation Oncology). Craig Lockhart, MD, MHS, (Medical
Oncology), Marvella E. Ford, PhD (Public Health Sciences), and Evan Graboyes, MD, MPH
(Otolaryngology and Public Health Sciences). The multi-PI team works hand-in hand with the clinical
research operational leaders at the MUSC/HCC and local clinical investigative team at the NCORP affiliate
location to establish and manage a robust clinical research operation to add value to NCORP. This
leadership team has also worked collaboratively with other committed clinical and cancer control
researchers, oncology care providers, cancer patients, and survivors in our catchment areas to advance
all types of cancer research through the NCORP research bases. The MUSC NCORP-MU aims to
improve fairness and access to clinical research in medically overlooked groups in order to enhance the
quality of cancer care delivery and reduce differences in cancer health outcomes within South Carolina
and communities across the US.

Public health relevance
PROJECT NARRATIVE Continuation of the Medical University of South Carolina NCORP Minority/Underserved Community Site will provide greater emphasis and availability for residents and healthcare providers of South Carolina to participate in cancer prevention and control, screening, post treatment surveillance, cancer care delivery, treatment, and imaging research studies.